Understanding and targeting molecular as well as structural events governing right ventricular adaptation, failure and recovery in pulmonary hypertension using repurposed drugs

Despite the clinical importance of the right ventricle (RV) in pulmonary arterial hypertension (PAH), surprisingly
little is known about the molecular and structural mechanisms of RV adaptive and maladaptive remodeling and
the transition to RV failure. This is particularly important when the RV is not the primary cause of RV failure,
but when a temporary support of the RV would be desirable until the primary cause can be fixed.
Approaches that normalize pulmonary vascular resistance (PVR) and reduce RV afterload would improve RV
function and reverse RV failure. Unfortunately, no currently available medical therapy is able to significantly
reduce PVR long-term in chronic PAH or thromboembolic PH (CTEPH). As RV failure is the most common
cause of death in PAH, approaches to support the RV to better adapt to an increased afterload are highly
sought after. In this proposal, we will focus on two pathological features that put the RV uniquely at risk for
failure: (1) cardiac fibrosis, that reduces RV systolic/diastolic function, disrupts the myocardial architecture, and
impairs the exchange of oxygen/nutrients and (2) impaired microvascular adaptation (= capillary rarefaction)
that results in RV ischemia. Both are controversially debated as to their role in RV adaptation, failure as well
as in recovery. We use a novel mouse model of pulmonary artery banding (PAB) and de-banding (de-PAB) to
quantitatively capture histological changes in the RV using 3-D deep tissue imaging and to link them to cardiac
function with cardiac MRI (CMR). As a deficiency in Bone morphogenetic protein receptor 2 (BMPR2) signaling
is thought to put the RV at risk for failure, we evaluate whether two repurposed drugs, Tacrolimus (FK506)
and Enzastaurin, previously shown by our group to increase BMPR2 signaling, assist the RV by reducing
cardiac fibrosis and improving vascular adaptation and accelerate recovery. Moreover, we have identified early,
RV specific expression of SNAIL1 in cardiac fibroblasts as a promising and druggable target to improved
cardiac fibrosis. We hypothesize that Inhibiting Snail and increasing BMPR2 with FK506 and Enzastaurin will
reduce cardiac fibrosis, improve capillary density and improve RV function in the pressure overloaded murine
RV. Our proposal has three significant parts, which are represented by our three specific aims: First, we will
target molecular events that govern RV fibrosis in the pressure overloaded RV with genetic tools and
repurposed drugs to improve RV function and strain as assessed by CMR in PAB mice. Second, we will
characterize the adaptation of the RV microvasculature in PAB mice and human RV PH tissue, construct a 3-
D model of the RV microcirculation to predict how structural changes in the RV influence fluid and diffusion
dynamics and third, we will study histological and functional recovery of the RV in a novel de-banding mouse
model. By studying and targeting RV adaptation and failure, we not only address the most important
cause of mortality in PAH but also help improve other diseases, in which the RV is uniquely at risk for
failure such as in chronic lung and left heart disease, CTEPH as well as congenital heart disease.

Public health relevance
Understanding how the right ventricle (RV) adapts to the increased pulmonary vascular resistance in pulmonary hypertension and which molecular mechanisms and structural changes lead to RV failure, will help us develop novel therapies to strengthen the RV and prevent RV failure. We will test two repurposed drugs, Tacrolimus (FK506) and Enzastaurin in our mouse model of RV pressure- overload, to evaluate whether they can prevent and reverse RV failure. Given that these two drugs are ready to be tested in clinical trials, our research is in line with the NIH’s mission to increase knowledge to enhance health, lengthen life, and reduce illness and disability by applying fundamental knowledge of RV adaptation.